Translational Research to Prevent and Control Global Infectious Diseases (Translational Global Infectious Diseases Research Center, TGIR).

PROJECT SUMMARY – Overall Component
Despite striking advances in the 20th and early 21st century, infectious diseases are dynamic, ever-evolving
global threats that cause significant morbidity and mortality in all populations worldwide. Within a single year,
Zika has emerged, massive outbreaks of cholera have occurred, and antimicrobial resistance has become a
critical international concern. This landscape demands new approaches to prevent and control infectious
diseases, and the training of new scientists to meet these demands. New approaches will require interpretation
of big data sets, including data from both the biologic sciences (“systems biology” and “-omics”) and advanced
epidemiology. This University of Vermont COBRE will be focused on Translational Research to Prevent and
Control Global Infectious Diseases. “The TGIR Center” (Translational Global Infectious Diseases Research)
will integrate a novel multi-disciplinary research team of biomedical and mathematical/computational scientists.
The team will work toward novel and impactful research to diminish the burden of globally-important infectious
diseases by bridging the culture gaps between the biologic and mathematical/computational fields of
biomedical research. Our center will leverage substantial existing strengths at UVM in Global Infectious
Diseases Research, and strengths in complex systems and computational modeling. A team of experienced
directors, scientific advisors/mentors, and two new core facilities (“Mathematical and Computational Predictive
Modeling” and “Human and Population Research”), will foster collaborative and novel research. The TGIR will
develop four outstanding, existing junior faculty under the mentorship of senior scientific advisors from three
UVM colleges and five departments. Institutional support will enable recruitment of three new junior faculty
and will provide space for a new Innovation and Collaboration laboratory, the latter also supported by the
proposed Alteration and Renovation component. Internal and external advisory committees will provide formal,
unbiased oversight. Junior faculty will find a robust, well-organized academic home in the TGIR COBRE: a
strong mentoring and career-development program, a center-wide seminar series and coursework, and
research support from multi-disciplinary senior faculty teams in both research cores.

Public health relevance
NARRATIVE – Overall Component Infectious diseases are dynamic and continuously evolving threats, which cause substantial morbidity and mortality in all populations. Toward the prevention and control of globally important infectious diseases, we propose the development of the Translational Global Infectious Diseases Research (TGIR) Center at the University of Vermont. The TGIR center will pair biomedical advances in human immunology and infectious diseases with improved quantitative methods and computational modeling for the analysis and integration of big data throughout the translational research spectrum.